Novel vascular smooth muscle cell progenitors in development and disease

Excessive and ectopic smooth muscle cells (SMCs) and smooth muscle-derived cells accumulate in
diverse vascular diseases but underlying mechanisms are poorly understood. Seminal work from our
lab as well as other labs indicate that SMC progenitors play a vital role in this process. In
paradigm-shifting studies, we recently identified pools of SMC progenitors in the lung that we
reasoned were primed to muscularize distal arterioles based on their location at the muscular-
unmuscular border of each pulmonary arteriole and their molecular signature of expressing SMC
markers and the undifferentiated mesenchyme marker platelet-derived growth factor receptor
(PDGFR)-β. Upon exposing mice to hypoxia, expression of the ligand PDGF-B by lung endothelial cells
and macrophages induces these "primed" cells to express the pluripotency factor Kruppel-like factor
4 (KLF4) and in each arteriole, one of them migrates distally and clonally expands. This
pathological muscularization results in pulmonary hypertension. Similarly, in atherosclerosis of
systemic arteries, our recent results indicate that a single or rare SMC marker+ cells gives rise
to most of the cells in an advanced plaque, and the vast majority of these cells have been shown to
express markers of macrophages, stem cells or undifferentiated mesenchyme but not SMCs. Remarkably,
our findings demonstrate that bone marrow-derived cells (most likely macrophages) non-cell
autonomously regulate the number of SMCs recruited into a plaque and suggest that the number of SMC
progenitors recruited into a plaque dictates the progression of atherosclerosis. Thus, these novel
SMC progenitors are critical to the pathogenesis of pulmonary hypertension and atherosclerosis, but
little is known regarding their origin, development, gene expression, maintenance and the
mechanisms underlying their role in disease pathogenesis. In this proposal, we will use mouse
models, isolated murine cells, human tissue and myeloid cells isolated from humans. We will
identify SMC progenitors in the aorta and meticulously characterize both these progenitors and
those in the pulmonary arterioles. In addition, we will delineate progenitor cell origins and
development as well as their role in morphogenesis of the tunica media.
Mechanisms underlying their clonal expansion in disease and the non-cell autonomous regulation of
progenitor cells will be investigated. Taken together, our research program promises to yield
seminal insights into this novel progenitor cell type that is vitally important for vascular
pathologies and thereby, provide therapeutic strategies for combatting lethal diseases of the
vasculature, such as pulmonary hypertension and atherosclerosis.

Public health relevance
Remodeling of blood vessels is a critical component of diverse vascular diseases. Recently, we identified a pool of specialized progenitors in the walls of vessels in the lung that play a critical role in this pathological remodeling, and initial studies suggest similar processes in atherosclerosis. The proposed investigations characterize these progenitor pools, delineate the mechanisms underlying their regulation in the context of vascular disease and thereby, facilitate the development of novel therapeutic strategies.